Development of Best-in-Class Pol-Theta Inhibitors

Project summary.
BRCA1 and BRCA2 facilitate DNA double-strand break (DSB) repair via homologous recombination (HR). Yet
BRCA1/2 are often mutated in cancers, such as breast/ovarian/prostate/pancreatic carcinomas. BRCA-deficient
cancer cells are therefore HR-defective, and susceptible to agents that induce DNA damage and/or prevent DSB
repair. For instance, Poly-ADP ribose polymerase 1 (PARP1) inhibitors (PARPi) preferentially kill BRCA-deficient
cancer cells and are approved to treat HR-deficient cancers. However, only ~60% patients respond to PARPi
and drug resistance is a major problem. Thus, developing second-generation precision medicines that target
HR-deficient cancers and/or overcome PARPi resistance is urgently needed.
DNA polymerase theta (Polq), a DNA repair factor important for microhomology-mediated end-joining
(MMEJ) of DSBs, has been recently validated as a druggable target in BRCA-deficient cancers. Polq is essential
for BRCA-deficient cancer cells, but is dispensable for BRCA-proficient cells, and Polq null mice exhibit no major
phenotypes. Recently reported Polq inhibitors (Polqi) showed preferential killing of BRCA-deficient cells. Yet,
these early stage inhibitors have significant deficiencies (i.e. poor ADME and PK parameters, or low potency)
which may limit their efficacy in clinical studies. We have developed a novel, oral bioavailable Polqi that exhibits
5.1 nM IC50 against Polq polymerase (Polq-pol), selectively kills BRCA-deficient cells, and exhibits better
pharmacokinetics than recently published Polqi. Our collaborative team (Pomerantz, Johnson, and Childers labs)
plans to further improve and demonstrate proof-of-principle of our novel Polqi as the potentially best-in-class
Polqi by developing the following Aims: 1. Optimization of Polqi via a prodrug strategy; 2. Biochemical and
cellular characterization of Polqi; 3. In vivo efficacy of optimized Polqi in BRCA-deficient solid tumors.
We expect that successful completion of these Aims will enable the development of a potentially best-in-class
Polqi prodrug candidate.

Public health relevance
Project narrative. DNA polymerase theta (Polq), a DNA repair factor important for microhomology-mediated end-joining (MMEJ) of DNA double-strand breaks (DSBs), has recently been validated as a drug target in BRCA1/2 mutated cancers in pre-clinical studies. Early stage Polq inhibitors (Polqi), however, have significant deficiencies which may limit their efficacy and development in clinical studies. Our collaborative team (Pomerantz, Johnson, and Childers labs) plans to develop a novel chemical entity as a potentially best-in-class Polqi by employing an innovative prodrug strategy which is expected to prolong its exposure and activity in vivo.